Aptamer engineering of lentiviral vectors for cardiac gene therapies

PROJECT SUMMARY/ABSTRACT
Overview: Hypertrophic cardiomyopathy is the leading cause of sudden death in young
individuals, where several loss-of-function mutations in key sarcomeric proteins cause
hypertrophy. Gene therapy approaches that drive the overexpression of the correct
genes can be used to remodel the heart tissue and restore function. However, no gene
therapies have been developed for in vivo targeting of the heart to date. A key bottleneck
in the field is the ability to engineer advanced viral vectors with prescribed tropism in the
patient’s body.
Lentiviral vector (LVV) engineering applies rational design principles to define
components of the vector envelope, such as attachment proteins, leading to vectors with
programmable tissue specificity and off-target activity.

Public health relevance
PROJECT NARRATIVE Hypertrophic cardiomyopathy is the most prevalent genetic cardiomyopathy affecting Americans (1/200 adults) with no current treatments. Our platform technology will devise Lentiviral vector (LVV) compositions decorated with aptamer and optimized for cardiac gene therapy, positioning us for life-saving, translational impact.